Developing MRI-Guided Preventive Dendritic Cell Vaccination Strategy to Avoid Post-surgical Pancreatic Cancer Recurrence and Metastasis

PROJECT SUMMARY
Pancreatic ductal adenocarcinoma (PDAC) is the third leading cause of cancer mortality in the US. Surgical
resection is the only curative treatment, and due to the high recurrence rate (60%), only 20% survive five
years. Chemotherapy and radiotherapy after surgical resection only offer modest improvements in survival. A
new approach to prevent tumor recurrence in PDAC patients is urgently needed.
We will compare overall survival (OS) after tumor resection between the combination of dendritic cell (DC)
vaccination via an improved intraperitoneal, i.p., route, combined with current therapy (gemcitabine), versus
the use of preventive DC vaccination alone or gemcitabine alone (Aim 1).
Given the relationship between migration to lymph nodes (LNs) and anti-tumor immune response, accurate
quantification of DC vaccine migration could serve as an early biomarker for predicting longitudinal response
(OS) and elucidating the cause of differential response rates between patients. Understanding factors that
affect DC vaccine response rates will enable the titration of vaccine doses to optimize outcomes for individual
patients. Thus, we will validate magnetic imaging via quantitative susceptibility mapping (QSM) and ultrashort
echo time (UTE) R2* techniques for tracking clinically applicable magnetic-labeled DC vaccines to draining
abdominal LNs (Aim 2).
We will test whether advanced MRI-tracked DC vaccine homing to LNs can be used as an early imaging
biomarker to predict OS of the combination of DC vaccination and gemcitabine treatment post-surgery (Aim 3).
The proposed work will meet the significant demand for a novel DC vaccination strategy of cancer therapy that
can rapidly be translated to the clinic to prevent relapse after pancreatic tumor surgery while adding an imaging
biomarker as a potentially powerful method to simultaneously predict response to the therapy.
The success of the proposed preventive DC vaccination strategy and prediction of response to treatment could
have a broad impact as a clinical extension to other solid organ systems (e.g., stomach, liver, colorectal, renal,
or uterine tumors) as novel adjuvant immunotherapy to prevent relapse after surgery.

Public health relevance
PROJECT NARRATIVE Pancreatic ductal adenocarcinoma (PDAC) has a high risk of recurrence and mortality even after removal and subsequent chemoradiotherapy. We will perform the first study of preventive dendritic cell (DC) vaccination combined with chemotherapy to prevent PDAC recurrence while simultaneously using imaging of migrating magnetically labeled DC vaccine to predict vaccine efficacy.